The Environmental Factors in FEtal to Childhood Trajectories Cohort

The Environmental influences on Child Health Outcomes (ECHO) Pediatric Cohorts program launched in 2016, bringing together more than 30 extant cohorts to investigate the roles of a broad range of early exposures on five key child health outcomes. In 2023, ECHO is expanded to include new sites starting recruitment in early pregnancy. We proposed to recruit the Environmental Factors in FEtal to Childhood Trajectories EFFECT cohort to participate in the ECHO program. EFFECT will be a prospective birth cohort of 2,800 individuals recruited prior to 20 weeks of gestation, their partners, and their children. The scientific premise of our cohort is that social and community exposure early in development play a significant role in the emergence of child obesity. Our Specific Aims are: Aim 1: Test the hypothesis that the interaction between chemical and maternal psychosocial exposures in utero interact to create differential childhood growth trajectories (growth latency and growth spurts) from birth to age 5. We will leverage survey and biomarker data collected under the ECHO core protocol to model the impact of concurrent in utero exposure to phthalates and maternal stress on childhood growth trajectories. Aim 2: Test the hypothesis that early life exposure to adverse psychosocial and community factors are associated with higher rates of child obesity. We will leverage specialized exposure data (maternal survey data) and specialized outcome data (measures of child obesity) to test the hypothesis that exposure to parental material hardship and psychosocial vulnerability is associated with higher rates of child obesity. Aim 3: Recruit and retain a robust cohort of 2,800 families and implement the ECHO protocol with high fidelity. We will leverage innovative participant-centric technological support as well as committed community engagement to achieve this Aim. Exploratory Aim 4: To measure the direct and interactive effects of preconception physiologic and psychosocial exposures on child weight outcomes. We will measure the direct and interactive effects of pre- conception adiposity and caregiver receipt of social support on early life measures of child obesity risk. Our proposed cohort and study team are perfectly positioned to meet the current needs of the ECHO program: 1) to address solution-oriented scientific questions of high priority; 2) to increase the number of enrolled participants; 3) to facilitate the enrollment of the non-gestational parent; and 4) to facilitate collection of preconception data.

Public health relevance
We will recruit 2,800 individuals prior to 20 weeks gestation, their partners, and their children into the EFFECT cohort to study how psychosocial and community influences before a child’s birth impact the development of child obesity. Our proposed cohort and study team are perfectly positioned to meet the current needs of the ECHO program: 1) to address solution-oriented scientific questions of high priority; 2) to increase the number of enrolled participants; 3) to facilitate the enrollment of the non-gestational parent; and 4) to facilitate collection of preconception data.